Core E: Clinical Translation Core

PROJECT SUMMARY/ABSTRACT
Improving cystic fibrosis (CF) outcomes have reshaped research priorities in this field. The
Clinical Translation Core (CTC) has continued to evolve to meet these research needs. In Aim
1, the CTC provides access to a broad collection of human biospecimens with associated
clinical data to investigators conducting basic and translational research. A specific focus on the
acquisition of intestinal biopsy samples during clinically indicated endoscopies provides these
hard to obtain samples. In Aim 2, the CTC provides access to comprehensive clinical research
expertise across gastroenterology, endocrinology, pulmonology, functional lung imaging and
biostatistical fields. Importantly, new expertise in diabetes, obesity, and metabolic syndrome has
been added to this core. This accumulation of experienced researchers will provide CTC users
with content area and study design expertise that is relevant to most major disease
manifestations and complications. Further, the embedded biostatistical expertise assists with
data analysis, database creation and management, feasibility and sample size estimations.
Finally, Aim 3 provides access to specialized pulmonary outcome measures that are well suited
to the testing of novel therapeutics, particularly for patients without access to highly effective
CFTR modulators, and children with mild disease. Support of these novel outcome measures
ensures their ongoing availability to the CF community.